Immunization against Multidrug-resistant Pathogens: Activating T Cell Immunity (IMPACT-CETR)

Overall Project Abstract
The overall focus of the “Immunization against Multidrug-resistant Pathogens: Activating T Cell Immunity” Center
of Excellence for Translational Research (IMPACT-CETR) is to advance promising multicomponent vaccines for
Staphylococcus aureus, Pseudomonas aeruginosa, and Klebsiella pneumoniae. These are among the most
important bacterial pathogens that cause severe clinical disease and death and yet are becoming increasingly
resistant to the most effective antibiotics. The overarching goal of this IMPACT-CETR is to harness the
collaborative team’s complementary expertise in immunology, bacteriology, bioinformatics, primatology, vaccine
development, and antigen-adjuvant formulations to achieve three deliverables: 1) novel multicomponent
vaccines optimized for bacterial proteins and/or polysaccharides that elicit broad and potent serotype-
independent protection against S. aureus, P. aeruginosa, and K. pneumoniae infections, including with resistant
and MDR clinical isolates; 2) defined key mechanisms of host protection and biomarkers of vaccine efficacy; and
3) nonhuman primate (NHP) models to characterize immunogenicity and surrogate markers of protection. The
proposed vaccine components are well-characterized, some are chemically defined, and all are designed for
feasible scale-up and manufacture. The three research projects in this CETR are bonded by the theme that
tissue-resident memory T cell responses, particularly tissue-resident Th17 cells, are critical for protective
vaccines against these pathogens. The translational research projects will develop countermeasures to
prevent/reduce disease caused by key resistant and MDR bacterial pathogens. Project 1 addresses a
multicomponent S. aureus vaccine formulated with conserved protein antigens using the new and innovative
Multiple Antigen Presenting System (MAPS) platform wherein fusion proteins of the avidin derivative rhizavidin
with conserved S. aureus protein antigens are complexed to a biotinylated polysaccharide to generate protective
B- and T-cells. Project 2 addresses a multicomponent P. aeruginosa MAPS vaccine based on the serotype-
independent P. aeruginosa biofilm polysaccharide Psl and its critical lipid epitope, combined with conserved
protein antigens including the Th17-eliciting antigen PopB. Project 3 addresses a quadrivalent K. pneumoniae
vaccine based on conserved proteins that elicit protective Th17 cells and antibodies. Vaccine candidates will be
tested in wild-type and transgenic and/or knock-out mice and in non-human primates. These projects will be
supported by an administrative core and three scientific cores that focus on bioinformatics, transgenic mouse
models for mechanistic studies, and NHP studies. The expected milestone for each project is the development
of a preclinical data package that would pave the way for subsequent IND applications and clinical trials.

Public health relevance
The emergence of multidrug-resistant (MDR) bacteria represents the single greatest threat to our ability to treat infectious diseases. Methicillin-resistant Staphylococcus aureus (MRSA) and MDR Gram-negative bacteria such as Pseudomonas aeruginosa and Klebsiella pneumoniae cause significant human morbidity and mortality, and the Gram-negatives increasingly often possess such broad-spectrum antibiotic resistance that there are very often few, or sometimes even no, available drugs to treat them. Broadly protective vaccines against these pathogens would not only decrease the burden of infections but also lead to lower overall antibiotic resistance due to less antibiotic use. This U19 proposal brings together investigators with wide and synergistic expertise for vaccine development, including immunology, microbiology, bioinformatics, and animal models of infection to develop and test new multicomponent vaccines that combine bacterial antigens to stimulate multiple different types of immunity that can work together to give the best protection from infection.